Development of Interracial Anxiety: Children's Lay Theories and Nonverbal Influen

PROJECT SUMMARY/ABSTRACT Kristin Pauker, Ph.D., is a postdoctoral scholar at Stanford University whose research focuses on children's understanding of race-related knowledge and the impact of this understanding on behavior. Specific to this application, Dr. Pauker plans to study how children's understanding of race- related knowledge (e.g., discrimination) and nonverbal influences in their environment (e.g., nonverbal behavior depicted in the media) affect the emergence of interracial anxiety and racial seggregation in children. Extant research has established links between discrimination and negative mental-health outcomes, particularly for minority children. Interracial friendships may provide one potential buffer against these negative outcomes through decreasing interracial anxiety and the overall prevalence of discrimination. However, despite continued efforts to improve race relations in America, interracial friendships often drastically decline around the 5th grade. The primary goal of this research is to examine what processes underlie this decline and subsequent self-segregation, and to uncover how to motivate children to approach interracial interactions with positive expectations. Dr. Pauker plans to conduct this research at Stanford University where she will work with experts in social development and race perception. Under the mentored phase, she will complete two studies. The first study tests whether children's understanding of discrimination fosters interracial anxiety and declines in interracial friendships in middle childhood. Specifically, it will measure the emergence of interracial anxiety in White and racial minority children ages 8-13 and examine the potential antecedents, behavioral correlates, and consequences of this anxiety as they emerge developmentally. Further, children's naïve or implicit lay theories about whether personality is fixed or can change should direct children's interaction expectations, behavior, and future motivations. The second study tests whether manipulating children's implicit lay theories can change their expectations, create positive interactions, and increase motivation for interracial contact and friendship formation. In the independent phase, a longitudinal study will be conducted to examine the contribution of discrimination understanding and implicit lay theories to changes in the trajectories of interracial anxiety and interracial friendships over this age-range. Moreover, a series of studies will be conducted to address whether such nonverbal anxiety can be conveyed through patterns of nonverbal behavior represented in children's environment (e.g., media, parents). The results of the entire set of studies will then inform a larger R01 application aimed at developing and testing an intervention to foster positive interracial interactions and increased interracial friendships.

Public health relevance
PROJECT NARRATIVE Discrimination-often associated with decreased mental health for particularly racial minorities- becomes increasingly salient in middle childhood. The current research should help uncover how different strategies for coping with the threat of discrimination may (a) shape children's anxiety in interracial interactions and (b) influence the maintenance of interracial friendships, a potentially important buffer against the negative effects of discrimination. Additionally, it will test two potential ways to foster positive interracial interactions and increase interracial friendships, in order to curb negative pathways early on and promote positive development. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Despite continued efforts to improve race relations in America, interracial friendships rarely survive the 5th grade (Aboud, Mendelson, & Purdy, 2003). Middle school-age children frequently self- segregate and avoid cross-race interactions (Schofield, 2007; Shrum, Cheek, & Hunter, 1988). Given that interracial friendships are essential to the reduction of continued prejudice (Pettigrew, 1998), they may provide an important buffer against negative outcomes linked to discrimination in minority children, such as reduced academic motivations and increased depression. Additionally, interracial friendships may even curtail the occurrence of discrimination among both White and non-White school children, altogether, through reducing interracial anxiety and improving interracial attitudes. Therefore, continued avoidance of interracial interactions ultimately has a detrimental effect on perceptions of other racial groups, school performance, and mental health. Left unchecked, such segregation, and its effects, may become all the more prevalent in the coming decade, as the non-White population is expected to reach close to 50% of the U.S. total by 2020 (U.S. Census Bureau, 2004). Thus, it is important to establish not just that racial segregation exists, but what factors lead to such behavior and how we might mitigate self-segregation. While little research has been done to date on the mechanisms underlying children's choice to self-segregate, such behavior is not surprising given what we know about adults. Grown-up interracial interactions are often stressful, anxiety provoking, and cognitively demanding for both White and non-White individuals (e.g., Blascovich, Mendes, Hunter, Lickel, & Kowai-Bell, 2001; Clark, Anderson, Clark, & Williams, 1999; Crocker, Major, & Steele, 1998; Richeson & Shelton, 2003; Shelton, 2003; Stephan & Stephan, 2001). Whites' concerns about appearing prejudiced or non-Whites' concerns about being the target of prejudice can lead to negative interactions (Pinel, 1999; Vorauer & Sakamoto, 2006), negative expectations of future interactions (Shelton & Richeson, 2005; Tropp, 2003), and avoidance of such interactions where possible (Plant, 2004; Plant & Butz, 2006; Plant & Devine, 2003; Shelton, Richeson, & Vorauer, 2006). Expectations about being perceived as discriminatory or being the target of discriminatory behavior likely also contribute to children's avoidance of interracial interactions. How do children develop such apprehension about interracial interaction? One factor may be the coinciding development of a concrete understanding of race and the social mores regarding discrimination. Interestingly, the period in which children's interracial friendships drastically decline corresponds with the age at which children become increasingly cognizant of discrimination and develop a more integrated racial consciousness (McKown, 2004). Another factor may be nonverbal anxiety transmitted through biases in nonverbal behavior displayed in their environment (i.e., via media or parents). Thus, both children's understanding of discrimination and how they cope with the expectation of being negatively stereotyped and subtle influences transmitted in their environment may directly impact their interracial relationships and, in particular, the maintenance of important interracial friendships. In sum, in order to address the needs of an increasingly diverse population, we must understand what predicts the emergence of anxiety in interracial interactions and the resulting self- segregation in children. While a considerable amount of work with adults has explored interracial interactions, and the antecedents and consequences of interracial anxiety in such interactions, work elucidating children's expectations, experiences, and perceptions of interracial interactions is virtually non-existent. This is surprising, given that interventions aimed at increasing individual motivations to positively approach interracial interactions are likely to be most influential before children's negative expectancies have solidified. Thus, the present proposal aims to: 1. Measure the emergence of interracial anxiety in White and racial minority children 2. Examine potential antecedents to this anxiety at the level of the individual child and how different components of racial knowledge (e.g., their stereotyping, attitudes, understanding of discrimination) coalesce to motivate behavior (e.g., avoidance of interracial interactions) 3. Examine potential antecedents to this anxiety at the level of the environment, focused on nonverbal anxiety conveyed via nonverbal behavior displayed in the media or by parents. 4. Develop an effective multi-level intervention that combines changes in children's implicit lay theories applied in an interracial interaction and exposure to positive nonverbal influence to create positive interactions and foster increased motivation for interracial contact and friendship formation